Serious Illness Communication Among Patients with Chronic Lung Disease and Comorbid Cognitive Impairment

PROJECT SUMMARY/ABSTRACT
Patients with chronic lung disease and comorbid cognitive impairment without dementia represent a large,
high-risk group with poor quality of life. Patients with chronic lung disease experience premature aging,
frequent hospital admissions, a high burden of symptoms, and poor quality of life. Patients with chronic lung
disease are more likely to have comorbid cognitive impairment without dementia than the general population,
and these patients have even worse quality of life. Serious illness communication is an iterative, complex
process that includes conversations between patients and clinicians in which patients explore their values and
priorities in order to ensure patients receive goal-concordant care.1 Thus serious illness communication with
this high-risk group is of paramount importance. Prior studies of serious illness communication among patients
with chronic lung disease have not characterized patients’ cognitive function or have excluded patients with
cognitive impairment. Understanding how serious illness communication differs among patients with chronic
lung disease with cognitive impairment without dementia compared to those with normal cognition is an
essential first step in learning how to best communicate with this high-risk population. The overall goal of the
proposed research is to determine how serious illness communication differs between patients with chronic
lung disease with comorbid cognitive impairment without dementia compared to those with normal cognition.
This will be accomplished in the following specific aims: 1) Determine differences in self-report of a serious
illness conversation, completion of a medical durable power of attorney for healthcare, and completion of a
living will among those who have lung disease and cognitive impairment without dementia compared to those
with normal cognition, and 2) Determine patterns of communication which are associated with patient
engagement in serious illness communication that occurred with patients who screened positive for cognitive
impairment. For Aim 1, data from the Health and Retirement Study, a nationally representative study of
approximately 20,000 adults >50 years, will be used. For Aim 2, a Conversation Analysis of serious illness
communication between a patient and a nurse and/or social worker as a part of the intervention in a clinical
trial will be performed to identify strategies leading to patient engagement.

Public health relevance
NARRATIVE Serious illness communication includes conversations between patients and clinicians where goals and values are explored as well as completing a living will or choosing a medical durable power of attorney. Patients with chronic lung disease and comorbid cognitive impairment who do not have dementia report poor quality of life, may experience unique barriers to serious illness communication, and are at risk for receiving care not aligned with their preferences. This study will determine how serious illness communication occurs differently among patients with chronic lung disease and comorbid cognitive impairment without dementia compared to those with normal cognition to inform future communication interventions.